Functional role of tachykinin 1-expressing lateral habenula neurons in flexible reward-guided behavior

PROJECT SUMMARY
Survival across species hinges on an animal’s ability to switch ongoing behaviors to optimize goals, such as
obtaining rewards, in dynamic environments. This process of adapting behaviors based on changes in
environmental contingencies, commonly referred to as behavioral flexibility, is impaired across many
neuropsychiatric disorders including depression, schizophrenia, and obsessive-compulsive disorder. A key
element of adaptive reward computations is reward prediction error (RPE) signals, which reflect the discrepancy
between obtained and expected rewards. The lateral habenula (LHb) plays a well-established role in signaling
RPE and has recently been more broadly implicated in adjusting choice behavior in response to changes in
reward contingencies. This suggests the LHb as a potential target for therapeutic intervention for diseases
characterized by inflexible behavior. However, the LHb is also involved in a diverse range of emotional and
motivational behaviors including stress, fear, aversion, aggression, and social and parental behavior. Therefore,
developing treatments that behavioral flexibility without risking a cascade of side effects first requires identifying
specific LHb subpopulations underlying flexible behavior.
In this proposal, we use cell-type-specific approaches to monitor and manipulate a genetically-defined neuronal
subpopulation found to preferentially signal RPE to determine how LHb RPE signals facilitate flexible behavior.
In our first aim, we will identify the neuronal coding mechanism used to encode reward prediction error in the
LHb. In our second aim, we will determine how these signals contribute to flexible reward-guided decision making.
Together these experiments will reveal the functional role of LHb RPE signaling in flexible behavior, which will
provide more refined insight into potential targets for tailored treatment of disorders characterized by inflexible
behavior.

Public health relevance
PROJECT NARRATIVE The ability to adapt ongoing behaviors in dynamic environments is impaired across many neuropsychiatric disorders. The lateral habenula performs computations that compare past outcomes to current outcomes in order to drive reward-guided decision making. The proposed project will inform a richer, cell type-specific model of how lateral habenula neuronal subpopulations monitor past outcomes to guide flexible behavior.